Project 1: Genetic Discovery Within Diverse Ancestry Cohorts

PROJECT SUMMARY
The genomics of Alzheimer Disease is complex and evidence to date suggests that different ancestry groups
have distinct genetic factors that influence risk. In this project, we will perform multiple statistical analyses of
generated genetic data in African American, African, and Hispanic/Latinx populations to identify genetic factors
that are distinct within those groups. We will develop and apply new methods for identifying regulatory elements
and leveraging admixed chromosomes that are features of these populations. Finally, we will summarize results
through polygenic and pathway analyses to identify specific molecular mechanisms that harbor genetic variants
influence Alzheimer risk in each of these populations.